Eastern Nigeria Research Ethics Training (ENRICH) Program

Eastern Nigeria Research Ethics Training (ENRICH) Program
Project Summary
The Eastern Nigeria Research Ethics Training (ENRICH) Program is a collaborative research ethics
training program to be implemented jointly by the University of Nigeria, Nsukka (UNN), NIH/FIC-funded Center
for Bioethics and Research (CBR) and University of Maryland School of Medicine (UMSOM). The program will
provide forty master’s degrees, two hundred short- and twenty-five medium-term trainings in research ethics
training to faculty members, members of ethics committees and individuals who are identified as potential leaders
in bioethics by their institutions in eastern Nigeria at the newly established bioethics degree program at UNN.
The program builds on a planning project implemented within the current CBR/UMSOM bioethics training grant
and is based on assessment of the needs of institutions and ethics committees serving approximately 50 million
people in eastern Nigeria. The program will rapidly scale up bioethics expertise and research capacity in eastern
Nigeria and ensure that the trainees conduct innovative, culture-specific bioethics research projects and expand
our contributions to the global research ethics discourse.

Public health relevance
Eastern Nigeria Research Ethics Training (ENRICH) Program Project Narrative The Eastern Nigeria Research Ethics Training (ENRICH) Program is a collaborative research ethics training program to be implemented jointly by the University of Nigeria, Nsukka (UNN), NIH/FIC-funded Center for Bioethics and Research (CBR) and University of Maryland School of Medicine (UMSOM). The program will provide 40 master's degrees, two hundred short- and twenty-five medium-term trainings in research ethics training to faculty members, members of ethics committees and individuals who are identified as potential leaders in bioethics by their institutions in eastern Nigeria.